An L-Aptamer-Displacement Assay for High-Throughput Screening of RNA-Targeted Small Molecule Antivirals

Project Summary/Abstract
While the vast majority of antiviral efforts to combat severe acute respiratory syndrome coronavirus 2 (SARS-
CoV-2) focus on essential viral proteins, emerging evidence shows that conserved viral RNA (vRNA) structural
elements are compelling targets with the potential for pan-antiviral activity. Despite this promise, however,
selective targeting of RNA using drug-like small molecules remains challenging. In particular, methodologies for
screening small molecule libraries against RNA remain underdeveloped, and do not adequately address the
central problem of target specificity. As a result, RNA-targeted screens often fail to yield efficacious compounds.
The proposed study takes direct aim at this technological gap through the development of a novel RNA-targeted
screening technology using L-aptamers composed of mirror-image L-DNA. The PI previously established that L-
aptamers can be evolved to bind native D-RNA structures, including SARS-CoV-2 vRNAs, with high affinity and
selectivity. He now proposes to develop L-aptamers into RNA-specific competitive displacement probes for
identifying small molecules with analogous properties. The general utility of nucleic acid aptamers, combined
with the unique RNA-binding properties of L-aptamers, impart the proposed L-aptamer-displacement assay with
several advantages over current RNA-centric screening technologies, and is hypothesized to facilitate the
discovery of small molecules with unprecedented RNA-binding capabilities.
The PI has already prepared an L-aptamer targeting a conserved RNA element with the SARS-CoV-2
genome, which will be developed into a biochemical assay that couples competitive displacement of the L-
aptamer from the vRNA target with an optical readout (Aim 1). Using this assay, the PI will initiate a high-
throughput screen to identify potent ligands targeting the corresponding vRNA. The most promising lead
compounds will be evaluated for antiviral activity against SARS-CoV-2 infected cells (Aim 2). Parallel efforts will
be undertaken to generate L-aptamers against additional SARS-CoV-2 RNA structures (Aim 3), which will be
shuttled through this same pipeline.
Successful completion of this project will signify a major advance in the area of RNA-targeted drug discovery.
While combatting SARS-CoV-2 is the immediate goal, technologies developed herein are readily adaptable to
target any RNA virus. By targeting essential RNA structures that are conserved across β-coronaviruses, the PI
envision that this approach will allow for identification of antiviral compounds with broad-spectrum activity that
might quickly pivot to address future outbreaks.

Public health relevance
Project Narrative Targeting of essential viral RNA structures rather than proteins is a potentially transformative antiviral strategy. This project seeks to develop a novel antiviral discovery platform that overcomes many of the challenges associated with selective RNA targeting, leading to increased productivity of RNA-targeted screening campaigns. The proposed technologies will be developed around severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2), with the goal of identifying RNA-targeted small molecules that inhibit viral replication.